Core--Administrative and Data Management and Analysis

The Administrative and Data Management Analysis Core provides central support to maintain the smooth functioning of the Program Project. Its goals are two fold; first, to maximize efficient use of investigator time by tracking expenses and preparing budgets, facilitating preparation of manuscripts and correspondence to the NIH regarding the PPG (example progress reports), ordering and receiving supplies, arranging equipment repair and compliance with institutional requirements (filing of protocols required for use of vertebrate animals, and adherence to environmental health and safety/biohazard and radiation guidelines), organizing twice-monthly meetings of the executive (Project and Core Leaders), twice-monthly meetings of the Internal Advisory Board, and one yearly meeting of the External Advisory Board; and second, to provide a cohesive and well-structured mechanism for tracking mice and data management and strong biostatistical support. The Core will be administered by Dr. Schmidt and Ms. Edwards, who have worked together and the other investigators extensively. Mr. Levitan and Mr. Weinberg have worked with Dr. Schmidt and the other project leaders for over three years. All projects and the other two Cores will employ this Core extensively.